Comparative transcriptomics of Plasmodium vivax strains to understand hypnozoite formation

PROJECT SUMMARY
Even though 60-85% of Plasmodium vivax (Pv) infections are caused by dormant liver stages, known as
hypnozoites (HZs), the molecular mechanisms that govern dormancy remain largely unknown. Without this
information, new interventions to eliminate HZs cannot be developed, and Pv malaria will continue to cause
substantial morbidity and socioeconomic hardships. The long-term goal of our research program is to understand
the molecular mechanisms that govern HZ dormancy so that these processes can serve as targets for new
therapeutics. The objective of this proposal is to understand how HZs are formed by addressing if Pv sporozoites
are pre-destined to develop into HZs or replicating schizonts (SZs) before or after invading a liver cell. This
information is needed because understanding how HZs are formed may lead to the identification of new
therapeutic approaches to eliminate them. Prior research has attempted to address if sporozoites are already
committed to dormancy prior to invading a liver cell, but the studies have been inconclusive because Pv
sporozoites with fixed, pre-determined fates have not been used. In preliminary studies, our team has overcome
this limitation by optimizing procedures to produce Pv North Korean, Brazil VII, and Chesson sporozoites. We
show that sporozoites from these strains develop into (1) nearly all HZs, (2) virtually no HZs, and (3) a mixture
of HZs and SZs, respectively, after invading primary human hepatocytes in vitro. The characterization of these
strains has provided the necessary technical innovation to determine if Pv sporozoites are pre-destined to
develop into dormant HZs or replicating SZs before or after invading a liver cell. Our central hypothesis is that
the fate of sporozoites is pre-programmed by distinct transcriptional programs that poise sporozoites to develop
into HZs or SZs. The rationale for this hypothesis is based on our preliminary data that these strains consistently
form the same proportions of HZs irrespective of the hepatocyte donor used or multiple passages through the
mosquito; therefore, fate must be pre-programmed in sporozoites. This proposal will test that hypothesis by
pursuing two specific aims. Aim 1 will test the hypothesis that Pv sporozoites are pre-programmed to develop
into HZs prior to hepatocyte invasion while Aim 2 will test the alternative hypothesis that development into a
hypnozoite is determined after hepatocyte invasion. The expected outcomes of this work is the determination of
when a Pv sporozoite commits to becoming a HZ and the molecular programs involved in this process. The
results of these studies will have an important positive impact because they may lead to the identification of new
therapeutic strategies to treat HZs.

Public health relevance
PROJECT NARRATIVE Plasmodium vivax is a major obstacle to malaria control and elimination due to its ability to form persistent liver stage forms known as hypnozoites. New therapies to eliminate hypnozoites are needed because these forms are responsible for up to 85% of P. vivax infections, and current therapies cannot be widely administered due to contraindications in large portions of at-risk populations. This project will address this public health problem by determining when and how P. vivax commits to dormancy, which is needed to develop new approaches to eliminate hypnozoites.